Using rebuilt AAA+ enzymes to uncover the mechanisms of proteolysis at the mitochondrial inner membrane

The mitochondrial inner membrane is the site of essential cellular functions such as oxidative
phosphorylation, phospholipid metabolism, and the regulation of apoptosis. These activities are
performed by a composite mitochondrial proteome that requires constant resculpting to respond
to both the changing metabolic demands of the cell and the emergence of damage driven by
reactive oxygen species. This resculpting is performed by two mitochondrial AAA+ proteases,
which harness the energy of ATP to recognize, unfold and degrade protein substrates both from
within and surrounding the inner membrane. In humans, dysfunction of these proteases has been
linked to the development of severe neurodegenerative disorders such as spinocerebellar ataxia.
AAA+ proteases assemble as hexamers to form an internal proteolytic chamber into which
substrates are forcibly translocated by a ring of ATPases. The study of the mitochondrial AAA+
proteases has been long hampered by their combination of multiple soluble catalytic domains with
insoluble transmembrane domains for anchoring into the inner membrane. We utilize a protein-
engineering approach to assemble previously membrane-constrained hexameric proteases in a
soluble, active form. Our goal is to use these rebuilt proteases to perform a rigorous analysis of
the mechanisms driving energy-dependent proteolysis at the mitochondrial inner membrane. The
first aim of the proposal is to define how substrates are selected for degradation among the myriad
mitochondrial proteins. Degradation signal sequences will be identified from physiological
substrates to ask whether these signals are conserved across diverse mitochondrial proteins to
enable recognition by common proteases. The second aim is to examine the recognition complex
formed between these proteases and specific substrates. A series of complementary biochemical
approaches will map the protease substrate binding sites and identify the complementary contacts
used to promote selection and degradation. Finally, we will examine how the architecture of the
proteolytic sites within the degradation chamber achieves specificity of peptide-bond cleavage
specificity, resulting in site-specific cleavage of a class of substrates, including the regulator of
mitochondrial fission. Together, these experiments will provide a rigorous mechanistic analysis of
the mitochondrial AAA+ proteases and provide foundational knowledge to aid the development
of small molecule modulators as future therapeutics.

Public health relevance
PROJECT NARRATIVE Mitochondria are the major energy producing organelles in eukaryotic cells and their dysfunction is implicated in many human diseases. AAA+ proteases help maintain mitochondrial activity by removing damaged and/or unneeded protein components in a timely fashion. This grant seeks to investigate how AAA+ proteases select and destroy specific mitochondrial proteins to shed light on the molecular basis of related human diseases.